Technology Enabled Services for Coordinated Care of Depression in Healthcare Settings

Abstract
Technology-enabled services (TESs), which use web-based and mobile applications for patients coupled with
support from a care coordinator, have consistently been shown through randomized controlled trials to be
effective at treating depression. However, attempts to implement TESs in healthcare settings have failed,
primarily because neither real-world patients nor providers use the tools we develop and evaluate in research.
This center addresses this research-to-practice problem through a multi-level strategy. At the research
proposal (RP) level, we will design and evaluate TESs for depression in three unique medical settings that
commonly manage depression. Each RP will include a unique design innovation. RP1 will design and evaluate
a TES to support a primary care collaborative care program. The design innovation of RP1 will focus on
integrating mobile phone sensing technologies to create simpler, more engaging patient tools. RP2 will design
and evaluate a TES for a specialty obstetrics care setting for postpartum depression. The design innovation
will focus on care manager-facing tools and processes that can simplify, organize, and automate workflows.
RP3, set in a geriatric service, will focus on homebound older adults, for whom there are few treatment options.
The design innovation will be to harness a voice-controlled intelligent personal assistant to support homebound
older adults, with supports for family caregivers. At the research level, we will harness the three RPs to refine
our Accelerated Create-to-Sustainment (ACTS) research framework, which aims to overcome the research-to-
practice gap in several ways. ACTS integrates human computer interaction (HCI) methods to incorporate the
voice of end users into the design and evaluation of the technologies, service protocol, and implementation
plan for the RPs, thereby ensuring that the end product is usable, useful, and can be implemented. Core
research design elements and measurements are consistent across the RPs, which will allow us to evaluate
the ACTS framework across all RPs to validate the core research principles of the ACTS framework. With the
help of our External Scientific Advisory Board, will use this experience to produce research guidelines for
digital mental health research, and aggregate the knowledge gained about TES and organization features into
a taxonomy that represents essential information for researchers and developers. We will achieve this this
work through a highly interdisciplinary team, led by two PIs who are leading experts in experts in digital mental
health and HCI (Mohr and Reddy), with additional expertise in medicine, implementation science, psychology,
research methods, and statistics. Each of the RPs is co-led by the clinic or service chief and a researcher,
thereby ensuring a deep collaboration between clinical service needs and research. Thus, this Center, by using
a multilevel approach focusing on both the individual research projects and methodology, will produce the first
TESs designed for implementation in real world healthcare settings, and will provide substantial and enduring
contributions to research methodology that will improve the quality of science.

Public health relevance
Narrative The Chicago ALACRITY Center will produce the first technology-enabled services designed to treat depression in 3 distinct care setting: family medicine, a specialty obstetrics care setting for postpartum depression, and a geriatrics service. The Center will harness the knowledge gained to provide substantial and enduring contributions to research methodology and knowledge representation that will improve the quality of science.